Genomics and Analytical Resource Core Section

The goals of our Center, Modifiers of FMR1-associated disorders: application of high throughput technologies, are targeted to the RFA research area to Advance the understanding of the pathophysiology of FMR1 Related Conditions. The completion of the proposed aims from the three research projects will lead to the identification of the genetic basis of variable expressivity or incomplete penetrance of FMR1-associated conditions. Project A will focus on the variable expression of epilepsy among boys with fragile X syndrome (FXS), a co-morbid condition that occurs among 15% of affected boys and we speculate that variation elsewhere in the genome is responsible. Likewise, Project B will focus on the incomplete penetrance of fragile X tremor/ataxia syndrome (FXTAS) in men, a neurodegenerative disorder among those with the premutation (PM), with a lifetime prevalence of 30% among males. Project C focuses fragile X association primary ovarian insufficiency (FXPOl) which manifests in 20% of PM carriers as premature ovarian failure (POF), or cessation of menses prior to age 40. POF leads to infertility and estrogen-deficiency related disorders usually reserved for the aged. Our goal is to identify and understand the extent of the epistatic effects of modifying genes on these three Mendelian disorders. The Center will include three projects and two shared cores, all administered by an Administrative Core. Each proposed research project will take the same novel approach to define a set of candidate genes for further study in mammalian systems. They will: 1) use the Recruitment Core B to ascertain the 100 cases and 100 controls drawn from extreme phenotypic tails of each disorder, 2) conduct whole genome sequencing on each of the 100/100 cases/controls series using the expertise and experience of the Genomics and Analytical Core C, and 3) after validating variants, assess the function of prioritized genes using the established phenotypic assays in the corresponding Drosophila models. This core will provide a common computational and analytical infrastructure for all projects, leading to natural economies and synergies including: 1) decreased costs due to larger sample sizes per experiment, 2) common equipment use, 3) increased quality control because all experiments use the same protocol, and 4) reduced errors in interpretation of results because of common analytical approaches. This final resource of 600 sequenced genomes of those with FMRI mutations will be available for future analyses by those in scientific community.

Public health relevance
The goal of this Genomics and Analytical Core (Core C) within the larger center is to provide the necessary experimental, computational and analytical infrastructure to obtain whole genome sequencing data on 600 samples, map that data to the human genome, find variants, validate those variants for further study, and perform statistical analysis of that data to test for association of variants or loci with phenotypes. The results generated by this core will be fundamental to all goals of this center grant.